Examining The Interplay Between Atrial Fibrillation, Anticoagulation, and Retinal Stroke - An Instrumental Variable Approach

ABSTRACT
Cardioembolic stroke (stroke coming from the heart) is the most lethal form of ischemic stroke, causing
sudden, permanent deficits in strength, sensation, speech, and sight. The most common cause of
cardioembolic stroke in older Americans is atrial fibrillation (AF), a chronic, cardiac arrythmia that can be
clinically silent yet portend a risk of life-threatening stroke. There are approximately 700,000 people with
undiagnosed AF in the United States. A recent NHLBI working group published recommendations for future
directions in cardiac monitoring, a strategy to detect clinically silent AF and – ideally – intervene before it is
too late. One facet of the recommendations was that individual clinical features should be used to target
cardiac monitoring in patients who may be at highest risk of clinically silent AF. Retinal stroke (central retinal
artery occlusion) is a disabling subset of ischemic stroke. It is not known whether AF is associated with retinal
stroke. Knowing whether AF represents an independent risk factor for retinal stroke would be valuable,
because it would motivate clinicians to pursue cardiac monitoring in patients with retinal stroke, and boost the
odds of detection of AF in this vulnerable patient population. Compelling preliminary data that AF is a risk
factor for retinal stroke is presented, however there are key limitations to its interpretation given the inherent
biases in observational literature. The current application proposes to do approach this question from a
distinct perspective. The central hypothesis of this proposal is that oral anticoagulation therapy modifies the
observed association between AF and retinal stroke. Testing this hypothesis provides indirect evidence of an
association between AF and retinal stroke, given that anticoagulation reduces thromboembolism in patients
with AF. During this project, the principal investigator will continue to receive intensive mentorship with an
added focus on instrumental variable analysis. An instrumental variable is a variable which is highly
associated with a downstream exposure (in this case anticoagulation) but not associated with the key study
end point (other than via its association with a downstream exposure) and not associated with unmeasured
confounding. Specific Aim 1 will construct an instrumental variable – individual prescriber preference for
anticoagulation use – and determine whether such a prescriber preference is associated with the hazard of
retinal stroke. Specific Aim 2 with determine whether changes in anticoagulation exposure within individual
Medicare beneficiaries is associated with the odds of retinal stroke, by means of a case-crossover design.
Results of this project – whether positive, neutral or negative – will inform our understanding of the biology of
retinal stroke, allow physicians to more appropriately counsel patients on the benefits and possible harms of
anticoagulation, and allow the refinement of instrumental variable analysis when applied to time to event data.
Completion of the proposed work will allow the PI to branch out into a new research direction informed by the
results of the parent K23 and advance his long-term objective of becoming an independent investigator.

Public health relevance
PROJECT NARRATIVE Strokes caused by blood clots coming from the heart are the most feared types of stroke and cause a high rate of death and disability. Retinal stroke is a type of ischemic stroke affecting the back of the eye whose mechanisms are poorly understood. In this study, we replicate some attributes of a clinical trial to examine the relationship between medicines which prevent strokes from the heart and retinal stroke, and generate data which could help doctors and nurses prevent retinal stroke in the future.